Improving high-risk infant care: from Hospital to Home with Neoneur Telehealth

Summary Abstract
Neoneur 921494 Improving High-Risk Infant care, From Hospital to Home with Neoneur
Telehealth (4.21)
The overall outcome for high-risk infants have improved significantly over the past two decades
with increased long-term survival and less major morbidities. The focus has shifted to defining
outcomes according to the quality of survival, with neurodevelopmental impairments being one
of the hallmarks of both prematurity and major congenital anomalies. Feeding remains a major
challenge for nursing care of high-risk infants, many who start life with a feeding tube. Poor
feeding is the most common reason for delayed discharge. Safe oral feeding is a particular
challenge for premature infants, and those born with complex congenital disorders, many of
whom are fed via a nasogastric tube initially or during recovery after surgery. Unlike other
critical physiological parameters currently there is no quantitative means to measure adequate
infant maturation (for the preterm infant) or recovery (for the cardiac infant) to safely transition to
oral feeding without respiratory risk. The Neoneur is a hand-held, mobile device, which uniquely
(issued patents 8473219, 8413502) measures patterns of oral cavity pressure, synchronized
with respiration providing the clinician with a quantitative assessment of feeding patterns. In
2019, Neoneur, LLC completed over 150 clinical interviews as part of the national I-Corps
program (NSF 1844816). Based on these interviews we hypothesize Neoneur’s measurements
are biomarkers that will improve quality of care and transitions to oral feeding, and by enabling
telehealth evaluation infants will get home earlier and decreases necessity for rehospitalization
due to poor weight gain. The technical effort supported by this proposal will advance the
capability of the Neoneur to provide the following: utility in the clinical setting, a means for
remote telehealth evaluations, demonstrated correlation to clinical relevance in infant specific
measurements and tracking, improve FDA application and claims, advance market adoption,
and investor readiness. This Fast-Track SBIR proposes to transform a research into a clinically
relevant device through the following aims. Phase l -upgrade prototype for manufacturability, -
clinical cleanliness, and telehealth functionality: Phase II - scale manufacturing, and performing
a study to assess safety and clinical value/utility. We will enroll 140 preterm infants and 140
infants with complex congenital heart disease and follow them from initiation of oral feeding in
the hospital and continue in the home for a maximum total of 12 weeks.

Public health relevance
Narrative Neoneur 921494 Improving High-Risk Infant care, From Hospital to Home with Neoneur Telehealth (4.21) The technical effort supported by this proposal will advance the capability of the Neoneur to provide the following: utility in the clinical setting, a means for remote telehealth evaluations, demonstrated correlation to clinical relevance in infant specific measurements and tracking, improve FDA application and claims, advance market adoption, and investor readiness.